Tracing Hypoxic State and Hypoxia Memory in Glioblastoma Progression

Hypoxia is linked to worse prognosis for cancers, including glioblastoma (GBM), the most common and highly
lethal primary brain tumor. Hypoxic tumor cells are thought to be better equipped to survive therapy and spawn
tumor recurrence, however, the trajectory of hypoxic cells during GBM expansion and their roles in recurrent
GBM after therapy remain poorly understood. The main goal of this proposal is to apply a dual genetically
encoded hypoxia-sensitive reporter system with lineage tracing capability to systematically characterize hypoxic
tumor cells during GBM progression. The dual reporter system distinguishes tumor cells that are acutely hypoxic
(marked by green fluorescence) from those with a history of hypoxia exposure (permanently marked with red
fluorescence). Their cell fate will be traced across time and space during GBM progression in both primary and
recurrent GBM models. The cellular study will be coupled with gene expression analysis on single cell level to
unravel the molecular underpinning of malignant potency of hypoxic tumor cells. By comparing transcription
profiles of acutely hypoxic versus hypoxia-exposed cells in primary and recurrent GBM, we will test the
hypothesis that there exists a hypoxia memory, i.e., hypoxia-exposed cells retaining a set of hypoxia-induced
genes that may be linked to survival fitness and tumorigenic potential. In conjunction to the descriptive part of
our study, we have also devised a genetic platform to selectively ablate hypoxic population with temporal control
to study their contribution to tumor progression in both primary and recurrent GBM. This functional data will
provide direct evidence to test the central hypothesis that hypoxia contributes to tumor progression, and more
importantly, tumor relapse after treatment. In summary, our innovative study will gain new insights into the link
between hypoxia and GBM malignancy, and set the stage for the discovery of new prognostic tools and
therapeutics targets to combat GBM.

Public health relevance
Low oxygenation (hypoxia) in tumor tissues is linked to worse prognosis for many cancers, including glioblastoma, a highly malignant brain tumor. Yet, the trajectory of hypoxic tumor cells during glioblastoma expansion and their roles in tumor recurrence after therapy remain poorly understood. This proposal will apply a genetically encoded dual hypoxia-sensitive reporter system with lineage tracing capability to systematically characterize the contribution of hypoxic cells to GBM growth and recurrence and to elucidate the molecular underpinnings.